Cortical and subcortical chandelier cell pathophysiology and symptomatology in autism

Abstract
This is a diversity supplement for Ms. Adriana Pantoja, first year graduate student at UCD Davis.
Ms. Pantoja will work in some novel aspects of aim 2a of the parent grant: Role of Chandelier
cells in the pathogenesis of Autism. Aim 2a proposes that that the number of Chandelier (Ch)
cells is differentially altered in two areas of the hippocampal formation. Ms. Pantoja will further
this aim by quantifying Ch cells in the third and fourth components of the hippocampal formation,
the subicular complex and the entorhinal cortex. The subicular complex and the entorhinal cortex
are interconnected with the components of the limbic system that is fundamental for regulating
learning, memory, and emotions, functions that are altered in ASD.
The suplementee professional goal is to accomplish her PhD degree by 2026, and then perform
postdoctoral training followed by becoming principal investigator of her own research laboratory.
During the period of this two years supplement, Ms. Pantoja will apply for a minority F31 grant.
She will receive career scientific and professional mentorship from Dr. Martínez-Cerdeño,
Professor of Pathology at UC Davis and a leader in Hispanic mentorship and outreach, and co-
mentor Dr. Randi Hagerman, clinical director of the MIND Institute.

Public health relevance
Narrative Ms. Pantoja will work in some aspects of aim 2a of the parent grant: Role of Chandelier cells in the pathogenesis of Autism. The suplementee professional goal is to accomplish her PhD degree by 2026, and then perform postdoctoral training followed by becoming principal investigator of her own research laboratory. During the period of this supplement, Ms. Pantoja will apply for a minority F31 grant. She will receive scientific and professional mentorship from Dr. Martínez-Cerdeño, Professor of Pathology at UC Davis and a leader in Hispanic mentorship and outreach.